Investigating Disease Activity, Bone Damage and Interleukin-1 Genes in Adult SAPHO Syndrome and Chronic Nonbacterial Osteomyelitis

Project Summary

SAPHO syndrome and chronic nonbacterial osteomyelitis (SAPHO-­CNO) is a painful and disabling
autoinflammatory disease primarily targeting bones and joints, with no FDA-­approved therapies. Severe sterile
inflammation of multiple bones (osteitis), driven by the interleukin-­1 (IL-­1) pathway, leads to irreversible bone
damage, chronic pain and disability in adult patients. Critical knowledge gaps remain about disease activity
assessments, risk factors for severe outcomes, and influence of variants in IL-­1 pathway genes on clinical
phenotypes in adults. This K23 proposal will propel our understanding of the longitudinal course of SAPHO-­
CNO in adults, garnering generalizable knowledge about this understudied and disabling autoinflammatory
disease. The proposed project will investigate clinician, patient and MRI-­assessed disease activity in a large
SAPHO-­CNO cohort (Aim 1), identify risk factors for bone damage in SAPHO-­CNO patients (Aim 2), and
discover IL-­1 signaling pathway gene variants and explore their correlation with clinical phenotypes in adults
with SAPHO-­CNO (Aim 3). The science resulting from this K23 award will lay the groundwork for a future R01
application. Dr. Aleksander Lenert is spearheading a unique prospective observational study in adult SAPHO-­
CNO (the SCS study) designed to address these knowledge gaps. His long-­term career goal is to develop into
an independent clinical investigator focused on patient-­oriented clinical and translational research in adults with
SAPHO-­CNO. Under direct mentorship from Dr. Polly Ferguson (world-­leading expert in CNO) and his
experienced mentoring team, Dr. Lenert will build on his foundational research skills to gain critical training and
hands-­on experience in agreement and psychometric analyses, latent trajectory modeling, genetic sequencing
analysis and interpretation, and prospective observational cohort study management. In addition to Dr.
Ferguson, his mentoring team includes Dr. Robyn T. Domsic (clinical investigator and observational cohort
study guru in systemic sclerosis), Dr. Daniel H. Solomon (leader in clinical science research in rheumatic
diseases), Dr. Mary Vaughan-­Sarrazin (experienced clinical outcomes researcher), and Dr. Jonathan Templin
(measurement science and applied psychometrics researcher). To further guide this scientific proposal,
develop focused training and aid his career development, Dr. Lenert has garnered the support of content area
experts in advanced imaging (Dr. T. Shawn Sato), and genetics and bioinformatics (Drs. Hatem El-­Shanti and
Benjamin Darbro). This proposal benefits from an exceptional scientific environment and established
infrastructure at the University of Iowa, including Dr. Polly Ferguson’s world-­renown center for the
management of patients with SAPHO-­CNO, and for clinical and translational research. Accomplishment of the
proposed Aims for this K23 award will directly benefit adults with SAPHO-­CNO, and lead to improved patient
outcomes. The K23 award will provide a framework for Dr. Lenert to acquire advanced methodologic research
skills and experiences necessary to become an independent clinical researcher in adult SAPHO-­CNO.

Public health relevance
Project Narrative The proposed studies in adults with SAPHO and chronic nonbacterial osteomyelitis (SAPHO- CNO), an understudied and disabling autoinflammatory disease, will significantly advance our understanding of how patient- reported symptoms and advanced imaging with whole- body MRI could improve disease activity assessments in the clinic, and will help identify potentially modifiable factors and symptom groups that are predictive of developing severe bone damage for earlier intervention. The discovery of mutations in inflammatory pathway genes may shed light on the spectrum of disease symptoms and complications in SAPHO- CNO, and these findings could be used to guide future clinical trials testing different treatment strategies in adult patients. Future research directions stemming from this work include the development of a patient- reported disease activity tool for use in the clinic, identification of novel biomarkers for earlier diagnosis, and deepening our understanding of long- term disease complications and responses to treatment, all of which would directly benefit adults with SAPHO- CNO.